Neuromodulation for Exercise Adherence in Older Veterans

Background: Fall-related hospitalizations and consequent morbidity and mortality continue to rise despite the
availability for over two decades of evidence-based fall-prevention programs. This is a major problem since
more than 2.5 million older adults are treated annually for fall-related injuries in the US. Fall-prevention
programs focusing on strength and balance exercises have been successful in facility settings but exercise
programs are ineffective at home due to lack of adherence. Estimates indicate that only 1 in 5 individuals
adhere to home exercise programs for fall prevention. Thus, there is an urgent need to improve adherence to
exercise performed at home by older adults seeking to improve balance for the sake of fall prevention.
Behavioral interventions have failed to consistently improve adherence to exercise. Biological reasons for poor
exercise adherence, such as executive dysfunction, have not been explored. Adherence to long-term exercise
is dependent on executive function (EF), which is controlled by the [dorsolateral prefrontal cortex (DLPFC)] of
the brain. EF influences choices in scheduling, forgoing competing activities, enduring subtle costs of time and
inconvenience, and the ability to delay gratification. Repetitive transcranial magnetic stimulation (rTMS) is a
non-invasive neuromodulation increasingly used for neural network specific interventions. rTMS of the DLPFC
improves EF, memory, motivation, and mental flexibility. rTMS studies to date have stimulated the motor cortex
for gait and balance improvements. The role of DLPFC in exercise adherence has not been explored. The
proposed study will be the first to test DLPFC stimulation for improving exercise adherence.
Objective: The study objective is to determine the effects of rTMS treatment of the dorsolateral prefrontal
cortex compared to sham on: [1. Short-term (2-wk) changes in executive function;] 2. Long-term (24-wk)
adherence to a home-based exercise program; 3. Long-term (24-wk) changes in balance and gait; and [4.
Short-term (2-wk) changes in self-efficacy and delay discounting.]
Methods: Sedentary community-dwelling older Veterans (age ≥ 65 years, [N=106]) will participate in a double-
blind randomized sham-controlled three-phase study. The proposed study will use Nintendo Wii-Fit exercises.
Phase I will include two weeks of facility-based exercise for safety assessment and learning the program,
followed by 12 weeks of home-based exercises. [Subjects with poor adherence and those with good
adherence with low EF] will then be randomized to rTMS or sham treatments. Phase II will include ten
consecutive weekdays of rTMS or sham treatment along with exercise training for subjects with poor
adherence [and for those with good adherence and low EF] and continuation of home-based exercises for
those with good adherence and EF. Phase III includes 24-weeks of a home-based exercise program. All
subjects will exercise for 45 minutes five days/week. [Objective measure of adherence collected from Wii-Fit
console and Conner’s continuous performance test for EF will be the primary outcome measures.] Balance
and gait will be assessed. [Self-efficacy, delay discounting along with fear of falls, and falls incidence will be
assessed. Outcome measures will be assessed at baseline, and at 14, 16, and 40 weeks.]
Significance: This project will have a major impact in improving adherence to an exercise program and in turn,
improve balance in sedentary community-dwelling older Veterans. At the end of the proposed project, we will
gain knowledge about the efficacy of rTMS in improving EF and exercise adherence. Knowledge gained about
the adherence to home-based exercises would be applicable to multiple conditions such as diabetes. Since
Wii-Fit and rTMS are readily available, translation of the study results to clinical practice would be expeditious.

Public health relevance
Lack of adherence to an exercise program is a major problem for older Veterans. Several fall prevention programs fail in the home setting due to lack of adherence. Exercise adherence is dependent on brain function among other factors. Magnetic stimulation of the front part of the brain improves brain function necessary for planning and following-through. [We propose a three-phase study in 106 sedentary older Veterans.] Everyone will be trained on use of the exergame, Nintendo Wii-Fit, that our team has found beneficial in improving balance and gait. They will be asked to exercise using Wii-Fit at home for 45 minutes daily five days/week for 12-weeks. [Those that exercise less than recommended dose and those that exercise adequately but have low executive function will receive either real or sham magnetic stimulation to the front part of their brain over ten sessions paired with exercise training.] All subjects will further complete 24-weeks of Wii-Fit home exercises. [Adherence, executive function, balance and gait, self-efficacy, delay discounting, and falls will be measured periodically.]